Control of CNS Myelination by the E3 Ligase Component Fbxw7

PROJECT SUMMARY
Myelination in the vertebrate central nervous system (CNS) is an evolutionarily conserved process where
oligodendrocytes (OLs), a glial cell type within the CNS, wrap surrounding axons in membrane sheaths providing
vital trophic support and insulation. This incredibly complex and dynamic process of myelination occurs
throughout life, both in response to injury and as a continuous refinement of circuit dynamics. A previous forward
genetic screen in zebrafish, aimed at identifying novel regulators of myelination, identified Fbwx7 as a negative
regulator of CNS myelination. Fbxw7 is a recognition subunit of the SKP1-Cullin-Fbox (SCF) ubiquitin ligase
complex. Loss of Fbxw7 resulted in a significant increase in myelin basic protein (mbp) expression, the number
of OL lineage cells, and an increase in the number of myelinated axons and myelin wraps in the dorsal spinal
cord of zebrafish. Additionally, loss of Fbxw7 in mature myelinating OLs in the mouse optic nerve resulted in a
significant increase in the density of abnormally thick myelinated axons, myelin outfoldings, and degenerating
axons, showing for the first time a role for Fbxw7 in regulating myelin homeostasis in the mammalian CNS. To
determine the substrates that Fbxw7 might be regulating to control CNS myelination, I silenced Fbxw7 in primary
OL cultures, and found a significant increase in the levels of the transcription factor Myelin Regulator Factor
(Myrf), a key protein essential for myelination, and many novel proteins. I hypothesize that Fbxw7 controls CNS
myelination by degrading protein substrates that regulate OPC proliferation, differentiation, and/or OL sheath
length and myelin thickness. To investigate this, I will 1) examine OL development and dynamics in Fbxw7 loss
of function zebrafish mutants and in OL lineage specific Cre mouse models, and 2) determine Fbxw7 substrates
that regulate OL development and myelination using zebrafish genetics and rodent culture models. By combining
these approaches, I will receive training in a diverse array of experimental methods and model systems, providing
me with skills and options to pursue a successful career in science. Additionally, my co-appointment in Dr. Ben
Emery’s (Jungers Center for Neuroscience Research) and Dr. Kelly Monk’s (Vollum institute) laboratories will
provide me with institutional support from two exemplary departments and access to a large group of diverse
PIs and trainees to aid in my scientific growth and training.

Public health relevance
PROJECT NARRATIVE The importance of myelination is highlighted by the devastating neurological symptoms that accompany diseases such as leukodystrophies and multiple sclerosis. Despite myelin’s essential function in maintaining the health of the CNS, the precise molecular mechanisms that regulate its formation have not been fully elucidated. Successful completion of this proposal will help uncover key molecular mechanisms that drive CNS myelination, potentially leading to new therapeutic targets.